Molecular biomarkers of future aggressive behavior in pituitary tumors

Project Summary/Abstract
A small subset of pituitary adenomas demonstrates aggressive behavior as defined by rapid growth following
treatment, namely hormonal therapy, surgery, and radiation. Aggressive pituitary tumors are devastating, life-
limiting malignancies with two patterns of growth: (1) they can remain confined to the skull base and grow
relentlessly, resulting in progressive neurologic dysfunction or (2) they can metastasize. These tumors are
poorly studied and under-recognized in part because there are no validated biomarkers that predict future
aggressive behavior. We hypothesize that recurrent patterns of copy number variation, including a molecular
hypodiploidy phenotype, characterized by an early, clonal loss of one copy of chromosomes 1, 2, 3, 6, 8, 10, 11,
13, 15, 17, 18, 21, and 22, predict future progression following treatment with radiotherapy. Additionally, we
hypothesize that aggressive pituitary adenomas and carcinomas harbor recurrent epigenetic and genetic
alterations at a gene and pathway level that define a more aggressive molecular subtype. This foundational
work is needed so that clinicians can prospectively identify tumors with a higher malignant potential. The
identification of a biomarker of aggressive disease is critical for improving patient outcomes by preventing both
over- and undertreatment, and for clinical trial development.

Public health relevance
Project Narrative Aggressive behavior in pituitary tumors is defined by rapid growth following standard treatment (surgery and radiation); at present, there are no biomarkers that reliably predict future aggressive behavior. We aim to identify these biomarkers by performing genetic and epigenic profiling on a unique cohort that includes patients with malignant tumors. The ability to identify patients with life-limiting tumors at an earlier stage would improve patient outcomes.